An Intervention to Reduce Cancer Associated Thrombosis Through Improved Prophylaxis

Candidate: Jordan Schaefer, MD is a hematologist and early clinical investigator specializing in antithrombotic
therapies, with particular interests in implementation science and cancer associated thrombosis (CAT).
Training Aims: This K01 career development award will facilitate Dr. Schaefer receiving training in qualitative
research methods and analysis. Furthermore, he will develop skills in implementation science, including
implementation mapping, and conducting a multicenter pilot implementation intervention. He will acquire these
skills through focused mentorship meetings, formal coursework, workshops and seminars, and experiential
learning. Long term, he will use this training to optimize and implement multicomponent interventions to
promote best antithrombotic therapies. Research Context: CAT is a leading cause of death among patients
with cancer. Studies have shown a net benefit to anticoagulant thromboprophylaxis for high-risk patients with
cancer receiving systemic cancer therapy. Guidelines have broadly endorsed offering apixaban or rivaroxaban
for this patient population, but uptake has been extremely low. An academic medical center was able to
increase prophylaxis rates to over 90% of eligible patients. However, this intervention is not generalizable to
community settings where most patients receive their care. The short-term goal of this proposal is to identify
strategies to improve rates of CAT prophylaxis rates in low resource, community settings with a long-term goal
of broadly disseminating this intervention to reduce the incidence of CAT. Specific Aims: AIM 1–To identify
determinants of CAT prophylaxis in community-based oncology care settings to develop a strategy for
improving CAT prophylaxis. AIM 2–To develop an implementation plan to improve the uptake of pharmacologic
prophylaxis for CAT using implementation mapping. AIM 3–To pilot an implementation intervention at
community-based oncology practices. Research Plan: To accomplish these aims, Dr. Schaefer will perform
semi-structured interviews based on the Theoretical Domains Framework at several oncology practices. He will
meet regularly with diverse stakeholders and use implementation mapping to establish a multicomponent
implementation plan. Finally, he will conduct a pilot test of the intervention and assess implementation
outcomes six oncology clinics. Research Environment: Dr. Schaefer is supported by a dedicated,
multidisciplinary team of accomplished mentors and advisors with whom he has previously collaborated. The
project will be supported by the Michigan Oncology Quality Consortium, the Michigan Anticoagulation Quality
Improvement Initiative, and make use of several resources available at the University of Michigan, including
the Institute for Healthcare Policy and Innovation. Summary: Completing this project will establish the
foundation for a larger, multicenter study to establish the clinical efficacy and sustainability of this intervention.
The training from this award will prepare Dr. Schaefer to submit a successful R01 application and achieve
research independence using implementation science principles to address complex anticoagulation problems.

Public health relevance
PROJECT NARRATIVE: Recent studies show that if preventative dose anticoagulation is provided to outpatients with cancer at high risk for clotting, it reduces the risk of cancer associated thrombosis, which is the leading non-cancer cause of death among this population. While guidelines suggest offering this potentially lifesaving therapy to high-risk patients with an acceptable bleeding risk, it is not routinely done. This study will identify strategies to improve the appropriate use of preventative anticoagulation for patients with cancer in diverse settings and pilot test an intervention to improve the quality of care patients with cancer receive.